RNA Regulation of Transcription Factor Activity

Project Summary/Abstract
Nimble and responsive transcriptional control is central to all processes of life, and hence this process is
regulated at a number of levels. During the last grant period, we discovered a robust, and unexpected, RNA-
binding activity inherent in representative proteins from two major classes of transcriptional factors (TFs): the
pluripotency factor Sox2 of the high mobility group box (HMGB) family and the glucocorticoid nuclear hormone
receptor (GR). Their RNA-binding activity was found to be mediated by their DNA-binding domains and directly
compete with DNA binding to their respective promoter or enhancer sequences. Furthermore, we found that
this activity was structure-specific rather than sequence specific in vitro. Both TFs strongly disfavored binding
ssRNA. Instead, the pluripotency factor Sox2 bound dsRNA regions while GR bound exclusively to RNA
hairpin structures.
These observations raise critical questions regarding the role of TF RNA-binding activity in transcriptional
regulation and provide the direct motivation for the research program described here. Our corroborating
discovery of RNA association of Sox2 in mouse embryonic stem cells confirms that direct RNA binding occurs
in vivo. The next steps are to further define and understand the specificity for the in vivo RNA targets and
determine the impact TF RNA interactions has on the transcriptional program. This includes refining our
understanding of what drives this RNA binding and determine how pervasive the activity is in other TFs.
We have developed an integrated and strategic research program to achieve these goals. Aim 1 capitalizes on
our observation that Sox2 directly interacts with RNAs in cells and develops this critical line of inquiry in GR to
develop a comprehensive RNA interactome including eRNAs. We will investigate whether transcription factors
use their RNA-binding activity to provide an alternate chromatin association strategy that impacts localization
and gene regulation. Finally, we take advantage of our biochemical insights to design and validate DNA- and
RNA-binding separation-of-function mutants, which will allow us to directly measure the impact of loss of RNA
binding on the transcriptome. In Aim 2, we turn to understanding the molecular nature of RNA association to
Sox2 and GR, first through the use of eCLIP strategies to identify consensus binding motifs and second
through high resolution structure determination of TF/RNA complexes. In Aim 3 of this program, we will
establish the generality of these observations to other important transcription factors, both within and beyond
the HMGB and nuclear hormone receptor families, as represented by Sox2 and GR, respectively.
Together, this proposal describes a comprehensive program seeking to determine the extent and role of RNA
binding in modulating the transcriptional program through interaction with classic transcription factors. The
impact of this program is high because understanding the roles of genome-wide pervasive transcription and
how this activity influences diverse cellular processes remains a major unanswered question in biology.

Public health relevance
Project Narrative Coordination of the cellular transcriptional program is central to all processes of life, including growth and differentiation as well as response to environmental cues. Emerging evidence suggests a primary role for coding and non-coding RNAs in mediating this response through direct interaction with transcription factors. Uncovering the mechanisms of action of this layer of regulation promises to reveal fundamental processes driving the transcriptional response as well as uncover new therapeutic targets.